CRYSTALLOGRAPHIC STUDIES ON NITRIC OXIDE SYNTHASES

Crystals of both the nNOS and iNOS heme domains are obtained in our lab. The unit cells were found rather large with the longest cell edge of 230-240 E. This poses problems in collection data beyond 3.5 E resolution in-house. Heavy dependence on the synchrotron x-ray facility at SSRL for data collections is expected for both native and heavy atom derivative crystals. MAD phasing techniques will be also attempted.